Retinal perivascular macrophages: ontology and function during neuroinflammation

PROJECT SUMMARY:
The blood-retina barrier is a key anatomical characteristic of the retina, which is disrupted in diabetic retinopathy
(DR), retinal vein occlusion, and posterior uveitis. Retinal perivascular macrophages are components of the
blood-retina barrier, yet their function is unknown. Brain perivascular macrophages are long-lived tissue resident
macrophages that reside on arterioles and venules, which regulate blood-brain barrier hyperpermeability. Our
preliminary data demonstrate that retinal perivascular macrophages are the major antigen presenting cells in the
retina and reside on post-capillary venules. Furthermore, retinal perivascular macrophages express a pro-
chemotactic transcriptome for monocytes, neutrophils, and lymphocytes. Additionally, we developed an effective
tool to target and deplete (Pf4Cre) perivascular macrophages without affecting microglia. Finally, after intravitreal
CCL2 injection, perivascular macrophage depletion severely hampers Ly6C+ monocyte infiltration. Based upon
these data, we hypothesize that retinal perivascular macrophages are long-lived tissue resident macrophages
that orchestrate transendothelial migration of immune cells during DR and uveitis. To test this hypothesis, we
formulated the following specific aims:
1) Determine the ontological origin of retinal perivascular macrophages. In this aim, we will use Cx3cr1CreER x
Rosa26GFP mice to fate map perivascular macrophages. We will label macrophages at the yolk sac and fetal
liver stages to determine perivascular macrophage origin. Additionally, we will perform pulse-chase labeling
studies to determine the longevity and bone marrow contribution over 1 year.
2) Determine the role of perivascular macrophages during experimental autoimmune uveitis (EAU). We will use
Pf4Cre x Rosa26LSL-DTR mice to deplete perivascular macrophages during EAU. Additionally, we will use Pf4Cre
x MHCIIflox mice to conditionally knockout MHCII in perivascular macrophages during EAU.
3) Determine the role of perivacular macrophages during diabetic retinopathy (DR). In this aim, we will use
diabetic Pf4Cre :: Csf1rflox/flox mice to chronically deplete perivascular macrophages and perform confocal
immunofluorescence of retinal flatmounts to quantitate immune cell infiltration at Month 1 and both pericyte
numbers and avascular capillaries at Month 9.
Completion of these aims will determine that perivascular macrophages are derived from fetal progenitors
without bone marrow contribution, are necessary for EAU initiation, and regulate immune cell infiltration during
DR. The blood-retina barrier is a key component in health and blinding diseases like uveitis and DR. These
studies will significantly advance our knowledge of perivascular macrophages and their blood-retina barrier
functions. Furthermore, they will potentially open a new therapeutic space, targeting perivascular macrophages
during inflammation and inflammatory retinal vascular diseases.

Public health relevance
PROJECT NARRATIVE Retinal perivascular macrophages are components of the blood-retina barrier, yet their function is completely unknown. Our preliminary data demonstrates that retinal perivascular macrophages reside on post-capillary venules, participate in antigen presentation, and express genes that stimulate immune cell chemotaxis. In this proposal, we will determine the origin and function of retinal perivascular macrophages during neuroinflammation, including experimental autoimmune uveitis and diabetic retinopathy; these experiments will potentially create a new therapeutic space, targeting retinal perivascular macrophages during posterior/intermediate uveitis and retinal vascular diseases like diabetic retinopathy and retinal vein occlusion.